Contribution of mast cells in non-allergic ocular inflammation

Ocular injury is a leading cause of corneal blindness, resulting in millions of cases of visual impairment globally
each year. Currently, the uncontrolled immune activation and tissue damage that occur following ocular injury
are treated with non-specific anti-inflammatory drugs (e.g. corticosteroids), which are rife with deleterious side
effects such as delayed wound healing and infection. Our research aims to identify the specific cellular and
molecular factors that mediate early immune cell activation and infiltration following ocular injury, so that novel
therapeutics may be developed.
Our group’s recently published reports and preliminary data have identified tissue-resident mast
cells as the primary reservoir of neutrophil-chemoattractants at the cornea, and have established that
instant release of preformed CXCL2 by mast cells is critical for early neutrophil migration (<1 hour) following
injury. Early-recruited ‘scout’ neutrophils subsequently release chemoattractant factors that drive a robust
second phase of neutrophil infiltration, amplifying the innate immune response. Excessive recruitment and
activation of neutrophils is known to cause deleterious inflammation and damage corneal architecture.
These observations pose a critical question: How do mast cells sense tissue injury and promote
early neutrophil recruitment? Our data show that damaged corneal epithelial cells (but not resident stromal
fibroblasts or macrophages) release inflammatory mediators that activate mast cells. In accordance with our
laboratory’s expertise in immunological assays and utilizing a well-characterized murine model of sterile
corneal stromal injury, we propose a series of novel experiments to decipher the role of mast cells as
sensors of tissue injury. In Aim 1, we will test the hypothesis that danger-associated inflammatory
molecules IL33, IL36γ and HMGB1 released from corneal epithelial cells activate mast cells in an IgE-
independent manner. Specifically, we will (i) establish that necrotic epithelial cells stimulate mast cells
relative to healthy and IL1β-treated epithelial cells using mast cell-specific tryptase and β-hexosaminidase
release assays; and (ii) identify the key danger-associated molecules expressed by corneal epithelial cells
that activate mast cells. In Aim 2, we will test the hypothesis that in vivo blockade of IL36γ function will be
more effective, relative to IL33 and HMGB1, in suppressing mast cell activation, resulting in reduced neutrophil
infiltration and tissue damage. Specifically, we will determine the effect of (i) silencing select mast cell-
activating mediators, and (ii) silencing receptors for select mediators on mast cells, on mast cell activation
and early neutrophil recruitment during corneal injury. We will also evaluate the therapeutic potential of local
blockade of select mediators. It is anticipated that this research will have significant translational impact
due to the high prevalence of ocular injury and inflammatory disease, as well as the relevance of mechanisms
governing neutrophil infiltration to non-ocular tissues.

Public health relevance
Notorious for being effector cells in IgE-mediated allergic disease, there is growing appreciation for the diverse IgE-independent immune functions of mast cells in a wide range of pathogenic states including autoimmunity, cancer and infection. Based on a robust foundation of recent publications and preliminary data, this application seeks to determine the specific cellular and molecular pathogenic elements that promote IgE-independent mast cell activation (and thus early neutrophil infiltration) in the setting of ocular injury, and thereby identify novel therapeutic approaches that could be useful in the management of eye injury and inflammation.